Optimizing encapsulation to treat Type 1 diabetes mellitus: the role of oxygenation, antigen shedding and innate immune response in graft success

PROJECT SUMMARY
The past fifty years have seen substantial advances in the field of encapsulation of
insulin producing tissues for the treatment of Type 1 Diabetes Mellitus. Persistent
obstacles and limitations of the current technologies have prevented translation of these
results to the clinical realm. Multiple groups are now poised for clinical translation, but
still lack adequate, easily retrievable delivery devices. One major obstacle is the
limitation of tissue loading in conventional encapsulation that results from the high
metabolic demand of native islets/SC-β and the concomitant mass transport limitations
of most encapsulation materials. Importantly, native islets experience oxygen and
nutrient deficit in loading densities greater than 1.5 to 2% v/v in standard alginate
microcapsules. In smaller capsules of alternate materials, mass transfer is impaired due
to monomer structure and cross-linking strategies. This adversely affects the benefit
afforded by the smaller diffusive distance.
Fundamental aspects of cell encapsulation must be reexamined. Research
efforts have been focused on the in vivo application where reduction in device geometry
is crucial to clinical success through the reduction of oxygen transfer distances and
overall biomaterial/graft volume. There has been little study of pre-transplant culture
where hypoxia and loss of viability/function are the result of cell proximity to the plastic
basal surface. This causes cell death and results in antigen shedding. In vivo, the
opposite holds true where larger geometry results in increased chance of hypoxia at
clinically relevant loading densities. The central hypothesis of this proposal is that
impaired oxygen mass transfer results in increased hypoxia/anoxia, loss of
function, apoptosis and antigen shedding. This proposal seeks to address these
obstacles through the following specific aims: 1.) we will determine the effect of capsule
geometry and pre-implant culture methods on encapsulated islet/SC-β viability, function,
antigen shedding and in-vitro inflammatory response from co-culture with macrophages.
2.) we will employ oxygen carrying perfluorocarbon nanoemulsions in islet encapsulation
devices in immune-deficient, immune competent and autoimmune mouse models
(BALB/C, C57BL/6, NOD-SCID, NOD) with chemical induction (STZ) of diabetes to
ascertain the additive effect of each on engraftment and restoration of normoglycemia.
!

Public health relevance
PROJECT NARRATIVE This project aims at resolving long-standing problems in the encapsulation of insulin producing cells. As several groups are now on the verge of clinical translation of their production of insulin-producing cell aggregates, there is a clear need for the optimization of these delivery technologies. Through our proposed analysis of potential obstacles to engraftment of these tissues, it is our hope that we will co-develop, with our collaborators, a methodology for delivering these cellular products and optimizing their viability and function prior to clinical procedures. The public health impact of this research is a substantial reduction in the existing burden on the health care system that is imposed by treatment of Type 1 Diabetes Mellitus and the associated co-morbidities. If successful, the proposed work will lead to interventions that alleviate this burden and help the millions of patients worldwide afflicted with Type 1 Diabetes Mellitus. !